NTP PROVANTIS SUPPORT IDIQ

Host and support Provantis for DTT use in capturing data during in vivo toxicology studies. This project includes the continual maintenance of the software, weekly export of collected data, annual training for users, and coordination during upgrades to minimize downtime for CROs using Provantis.